Minimally Invasive Molecular Approaches for the Detection of Barrett’s Esophagus and Esophageal Adenocarcinoma

PROJECT SUMMARY/ ABSTRACT
Esophageal adenocarcinoma (EAC) is a lethal cancer with poor outcomes (5-year survival <20%), when
diagnosed after the onset of symptoms,1but survival is excellent when diagnosed early.2 Esophageal intestinal
metaplasia, or Barrett’s esophagus (BE), is the only known precursor of EAC and progresses to EAC via the
development of dysplasia. EAC can be prevented by endoscopic therapy of dysplasia.3, 4 Hence endoscopic
screening for BE and endoscopic surveillance to detect dysplasia and EAC, followed by endoscopic therapy to
prevent EAC in those with dysplasia are recommended.5 Barriers to BE screening include the lack of accurate
and user-friendly BE risk assessment tools and the invasiveness and high cost of endoscopy.7 Further, screening
is recommended only in those with chronic gastroesophageal reflux (GERD), despite 50% of BE/EAC patients
not reporting GERD symptoms. Endoscopic surveillance also misses 33% of prevalent EAC & dysplasia, due to
the patchy distribution of dysplasia/EAC, and inadequate biopsy sampling. 8Hence the overall effectiveness of
the current EAC interception strategy is severely compromised.9 In the current grant cycle, we have made
substantial progress in identifying solutions to these barriers. We have developed an artificial intelligence
powered automated BE risk tool, which integrates clinical data from the electronic health record and is
substantially more accurate (AUC 0.84) than current guideline endorsed risk criteria (AUC 0.5-0.6). We have
also developed and validated an office based, nurse administered non-endoscopic BE screening test, which
combines a swallowable cell collection device (sponge on a string: SOS) with three methylated DNA markers
(NDRG4, VAV3, ZNF682). The test has good sensitivity and specificity for BE detection compared to endoscopy,
particularly for BE with high grade dysplasia and EAC. We have also discovered and validated additional DNA
markers that are highly accurate (AUC 0.92) in differentiating dysplasia/EAC from non-dysplastic BE (hereafter
“BE surveillance test”).15 These biomarkers are assayed from endoscopically collected whole-field brush
cytology specimens, which are anticipated to reduce sampling error and increase dysplasia detection. In specific
Aim 1, we will measure and compare BE screening rates with and without a multicomponent intervention in a
pragmatic cluster randomized trial. In specific Aim 2, we will select final DNA markers, then train and test the
final algorithm of the BE surveillance test. In specific Aim 3, we will perform an economic analysis of biomarker
enhanced non-endoscopic BE screening and BE surveillance, using microsimulation modeling to assess the
optimal thresholds under which the BE risk tool followed by the SOS BE screening test increases benefits and
reduces harm. The model will incorporate inputs from the literature, and completed trials in the current grant
cycle, to determine optimal thresholds for cost-effective screening. Utilizing innovative, non-endoscopic,
molecular, and modeling approaches, this proposal will favorably impact BE detection and surveillance,
enabling effective treatment, and improved EAC outcomes.

Public health relevance
PROJECT NARRATIVE Esophageal adenocarcinoma is a cancer with poor outcomes when diagnosed after the onset of symptoms. It arises in a precancerous condition called Barrett’s esophagus. In this proposal, we aim to test the cost- effective implementation of a non-endoscopic approach to the diagnosis of Barrett’s esophagus, dysplasia, and adenocarcinoma, using a capsule sponge-biomarker panel, in primary care and further development of an endoscopic brush combined with a DNA marker test, to enable the early diagnosis and prevention of this lethal cancer.